Advancing novel survey tools to increase participation and improve sexual and reproductive health data quality

PROJECT SUMMARY/ABSTRACT
The Institute of Medicine’s report on “The health of Lesbian, Gay, Bisexual, and transgender People,” called for
NIH-supported research to address the methodological challenges that have impeded research on the health
of transgender people – specifically, to improve strategies for reaching, larger, more diverse samples of
transgender persons in the United States. Historically, research on sexual and reproductive health (SRH) has
excluded or misclassified transgender, nonbinary, and intersex (TNBI) people due to presumptions that
pregnancy and related outcomes can be experienced solely by cisgender women. However, TNBI people plan
for and carry pregnancies, and thus require high-quality and evidence-based healthcare. Despite this need,
existing data on the SRH needs of TNBI populations primarily come from convenience samples-- small in size
and/or limited in geographic scope. The dearth of representative data has meant, critically, that SRH providers
do not have adequate evidence upon which to rely to ensure that the SRH needs of their TNBI patients are met
within existing healthcare services--thereby contributing to lower quality care and SRH disparities among these
populations. And while data on transgender and nonbinary people are scarce, data on intersex people are
even scarcer. Consequently, this study aims to test methods of improving the research participation, retention,
and quality of collected data among TNBI people in the United States. The specific aims include: (1) recruit a
large, diverse sample of TNBI people from across the United States, (2) collect longitudinal data on core SRH
outcomes, and (3) improve retention and data quality among TNBI participants in SRH research as compared
to standard methods. To achieve these aims, we will implement a four-arm, parallel design, randomized control
trial that randomizes participants to receipt of zero, one, or two novel survey features in their online survey: a
gender-inclusive anatomical organ inventory for screening into survey logic, and/or customizable survey
language to personalize their survey experience. The control group will be randomized to screening based on
a 2-part gender identity question, and use of standard medical terms. The research will address challenges
encountered in previous SRH research with TNBI populations and will contribute to the evidence around best
practices for data collection with other populations historically characterized as “hard-to-reach” in the context of
SRH, public health research, and clinical care. The evidence generated by this study could have wide-ranging
impacts—including refined determination of research and clinical care eligibility, improved research
participation, and better healthcare screening and treatment for TNBI populations. Beyond SRH and advancing
the evidence-based for TNBI people, this novel survey methodologies tested in this study could be applied
broadly to advance public health research approaches and improve the accuracy and relevance of data
collection with a diverse range of populations and topics.

Public health relevance
PUBLIC HEALTH RELEVANCE/PROJECT NARRATIVE Population-level data on the sexual and reproductive health (SRH) needs and experiences of transgender, nonbinary, and intersex (TNBI) people in the U.S. are virtually non-existent. To further the cross-cutting goal identified by NICHD’s Strategic Plan 2020--of addressing health disparities for sexual and gender minorities-- this study will collect rigorous, foundational, epidemiological data on SRH risk factors and outcomes among a large, diverse sample of TNBI people from across the United States; data that are essential to designing effective public health interventions informing evidence-based healthcare, and improving health outcomes. Further, this study will test and evaluate innovations in study design and survey methodology that will improve recruitment, retention, and data quality in studies of marginalized populations across disciplines.